A Framework for the Impact of Algorithms in Health Care

Health care algorithms make decisions that impact the lives of millions of individuals, yet few are rigorously evaluated for impact after they are implemented. Unfortunately, these oversights have led to the perpetuation negative health impacts. In an effort to leap ahead of the current state of the field, our research would build a framework for assessing the impact of health care algorithms before they are deployed, which is a novel line of investigation. This proposal is inherently interdisciplinary, spanning machine learning, AI, health economics, decision sciences, statistics, health policy, and qualitative research. Mathematical decision science microsimulation models will be developed, positing an underlying complex causal network of the health care system. In order to initialize these microsimulation models, a broad collection of data sources will be used, including health care billing claims, primary care electronic health records, and qualitative information. Primary outcomes under consideration center health care access, quality, and costs. Robustness and rigor are central to our work. Despite no comparator framework existing, we will additionally develop simpler causal network models along with Markov cohort models to provide a basis for comparison. Outputs produced will also be freely shared in the form of open-source code and open-access preprints featuring transparent descriptions of all models and assumptions. This work would involve a substantial shift in focus for the Principal Investigator; pivoting to research that leverages mathematical decision science modeling and qualitative approaches while merging them with her expertise in machine learning for health care. Importantly, this framework has the potential to influence a new set of standards and guidelines for AI algorithms, establishing a blueprint where tools are routinely evaluated for impact before deployment. Thus, creating this first-of-its-kind impact framework could transform the development and application of algorithms in health care, representing a substantial paradigm shift with broad impact.

Public health relevance
Algorithms continue to proliferate in the health care system, often with substantial implications for health outcomes. This research proposes building a framework for evaluating the impact of algorithms in health care before they are deployed using mathematical decision science modeling. Developing this open-source framework will have the potential for broad impact in improving health outcomes with a flexible design to allow adaptation to many health settings.